Telemedicine for Patients with Limited English Proficiency: A Mixed Methods Approach to Identifying and Addressing Disparities

PROJECT ABSTRACT/SUMMARY
Patients with limited English proficiency (LEP) are defined as “those who cannot effectively communicate in
English”, make up nearly 9% of the U.S. patient population.13 Patients with LEP are one of the groups most
underserved by the U.S. health system. They experience poorer access to care, face worse quality and safety
outcomes, and report lower levels of satisfaction with their care.14–16,18 Utilization of telemedicine, the provision
of remote clinical services via two-way synchronous communication, has demonstrated efficacy in certain
settings and has been proposed as a general means for reducing health disparities. 1–4 5 However, studies
prior to the COVID-19 pandemic have indicated patients with LEP also face disparities in accessing
telemedicine-based care.20–23 As the COVID-19 pandemic continues, it is clear that telemedicine will remain
part of the U.S. health system,11,12 therefore it is essential to assess how social determinants of health may
affect vulnerable groups’ ability to receive equitable telemedicine-based services. We propose a mixed
methods sequential explanatory design approach to identify and address barriers and facilitators related to
providing telemedicine care to patients with LEP, with a focus on the intersection of other social determinants
of health. Our approach will allow us to determine what may quantitatively drive disparities in utilization, which
will then inform a qualitative assessment why these disparities exist and how they may be resolved.25 The
specific aims are to 1) perform a longitudinal, retrospective analysis comparing telemedicine utilization and
total outpatient utilization, prior to and during the COVID-19 pandemic by LEP patients to that of English
proficient patients, 2) to qualitatively investigate how telemedicine visits are provided to patients with LEP
through semi-structured interviews with healthcare professionals working/interacting with LEP patients (e.g.
providers, community health workers) and Spanish-speaking patients with LEP. For both aims, we will consider
how the multi-faceted contributions of social determinants of health relate to the delivery of high-quality,
equitable telemedicine-based services to LEP patients. The results will be utilized to inform an evidence-
based toolkit of best practices for equitable telemedicine delivery for patients with LEP in an outpatient setting
to be evaluated in future studies.

Public health relevance
PROJECT NARRATIVE Patients in the United States who cannot effectively communicate in English are said to have “limited English proficiency” and encounter inequitable access to in person medical care. The proposed research will study the extent to which patients with limited English proficiency accessed telemedicine-based care during the COVID-19 pandemic, how they accessed telemedicine, and identify ways in which telemedicine can be more equitably delivered to patients with limited English proficiency.